Core B - Biostatistics

Project Summary/Abstract
The Biostatistics Core facility provides the statistical design, data management, and computational support for
all Leukemia SPORE investigators. The Core will support consultation and collaboration on all aspects of study
design, database development and quality control, and analysis and interpretation of data. The statisticians
participating in the Biostatistics Core bring established collaborations and a broad range of expertise and
experience in clinical trials, laboratory experiments, genetics and genomics research, and epidemiology
studies. Dr. Graham Colditz, Katherine Trinkaus, and Feng Gao, have extensive experience as investigators
and statisticians within the Hematopoietic Development and Malignancy Program at Siteman. Dr. Petti brings
bioinformatics expertise and a record of collaboration with Drs. Welch and Ley. The team brings expertise in
monitoring minority accrual, OnCore, REDCap and data management/analysis for clinical studies. Collectively,
these individuals have affiliations at Washington University School of Medicine and the Siteman Cancer
Center. The Biostatistics Core members have participated regularly in the investigator meetings for the SPORE
projects over the past 5 years and in design of developmental projects and career enrichment program where
they provide support and training for junior investigators. The specific aims of this core are to; 1: Provide
biostatistical and bioinformatics collaboration for Projects, Developmental Research program and Cores in the
SPORE, to assure robust statistical methods support the projects; 2: Provide biostatistical and bioinformatics
support and training to junior investigators through the CEP.

Public health relevance
PROJECT NARRATIVE During recent decades, the development and application of new statistical methodology for cancer research has resulted in an expanded role for statisticians. The Biostatistics Core provides the statistical, bioinformatics, and computational support for all Leukemia SPORE investigators. The Core will support consultation and collaboration on all aspects of study design, database development and quality control, and analysis, interpretation, and presentation of data.